Technology, Cognitive Work, and Patient Safety: A Information-Oriented Model

DESCRIPTION (provided by applicant): Managing information for safe care, especially in the new health IT environment, continues to be cognitively challenging work for care providers. Adequate cognitive support to providers when building health IT systems can increase provider effectiveness in their work by reducing workarounds and medical errors. To model information support, cognitive engineers traditionally have modeled the task-technology-people triad. But, preliminary work from the investigator suggests that low-level information really binds care tasks and how providers perform their tasks with technologies. The researcher has piloted an information-based cognitive work design technique for modeling low-level healthcare information providers create, use and share in their cognitive work. The technique, when extended to medical error modeling, will improve patient safety. However, for the extension to succeed, the researcher needs to enhance her skills in health informatics, and medical error modeling in addition to acquiring a comprehensive understanding of health outcomes modeling. This Pathway to Independence (K99/R00) grant application describes a training and career development plan that will allow the candidate, a Post Doctoral Research Fellow in the Quality and Safety Research Group at Johns Hopkins School of Medicine to achieve these objectives. The training component will be carried out under the mentorship of Dr. H. Lehmann (JHU SOM, Health Informatics). Drs. Peter Pronovost (JHU SOM, Patient Safety), Ayse Gurses (JHU SOM, Patient Safety) and Ann Bisantz (SUNY, Buffalo, Cognitive Systems Engineering) will provide additional mentoring in their areas of expertise. The long-term goal of this Pathway to Independence (K99/R00) project is to design health IT systems for provider work based on low-level information they create and use for care. During the award period, research will be focused on the following specific aims: (1) Map provider process workflows corresponding to patient state changes; (2) Identify low-level information attributes providers create and use in care processes, and relate them to potential medical errors at each major care process step; and (3) demonstrate utility of low-level information attributes as design bases for health IT support systems.

Public health relevance
Project Narrative (Public Health Relevance) Project aims are to understand and model how health care providers create, use and transform health information in their work. When health IT support systems are designed based on information providers create or use in their work, workarounds will be avoided, so medical errors from poor health IT support systems can be reduced. __SpecificAimsTextDelimiter__ Specific Aims Poor information support for the cognitively demanding work of care providers continues to cause significant medical errors and remains a challenge1-3. Cognitive engineers have attempted to address the challenge by modeling the task-technology-people triad4. The underlying rationale of the triad is people perform tasks in a system with technology, so if tasks can be designed to match people and their skills in using technology, and if technology can be made user-friendly5-9, the task will turn out to be effective. Tasks are typically designed as high-level surface features in a technology. For example, the discrete task steps to enter patient information (name, age, allergies, severity level, etc.) may be to type the information and check a box, or type the information and click submit, designed as fields in an interface. But, a closer examination of provider tasks will reveal that they are really creating, sharing or using information by doing their tasks. Similarly, providers are using technologies only to create, share or use information. Tasks and technologies are only means providers use to get to information (end). Indeed, information really binds providers, their tasks and the technologies they use, and is central in supporting provider cognitive work. Yet, information providers create and use for patient care is not a part of the cognitive engineering triad, and is rarely the focus in designing cognitive work support for providers. We know how people forage and search for information10, and how providers bundle patient information11. But, we do not know how and what information providers create and use, and how information is linked. Specifically, we do not know the nature, form and attributes of deep, low-level information providers use to cognitively support their care tasks. Some examples of low-level information attributes from our preliminary work are whether information is shared and with whom (e.g., nurse creates it, but physician may also use it), whether the information needs any annotation (e.g., vitals information needs to be salient to capture abnormalities), whether information needs to be stored temporarily (e.g., reminder information about a patient needs to be stored only temporarily until the task is complete), etc. Without knowledge and representation of low-level information, information support systems will continue to be ineffective, and result in medical errors. The utility of low-level information for designing cognitive work support is: (1) it will reduce frustrating, inefficient and cognitively demanding workarounds. Because tasks depend on technology12, if the technology does not have features to support a task, providers have to workaround the technology13, and still be careful not to make mistakes. However, because information is the object of action, it is independent of how a task is done, what technology is used for the task, or who does the task, reducing workarounds; (2) the disparate pieces of information the provider creates and uses are linked, and can cue other providers about care decisions, and can help overcome information silos. Additionally, information pieces contain positive design opportunities and embed strategies14 providers form and use for care. To overcome the gap in knowledge, the PI will use a new information-based cognitive work design technique15, 16 she has piloted to model low-level information. The technique captures: (1) descriptors for 16 unique low-level information providers create and use (2) the links between low-level information and corresponding higher level care processes; and (3) links between low-level information, workarounds and medical errors. The study focus is the discharge process because it is complex and information rich, discontinuous, with a potential for expensive readmissions17, 18. Specific aim 1 will be performed in the K99 phase at Johns Hopkins Hospital. Aims 2 and 3 will be performed in the R00 phase. Specific Aim 1: To model the discharge process flow where providers create and use low-level information, the PI will map major discharge process events depicting patient and discharge process state changes. We will qualitatively analyze provider interviews and focus group data. Specific Aim 2: To identify low-level information attributes of major discharge process events and relate them to workarounds and medical error, the PI will use the information-based work design technique to tag the discharge process flow map with: (a) low-level information providers create and use for discharge from provider observations, shadowing and interviews and (b) past and potential errors from adverse-events data, and care provider interviews, and (c) provider developed strategies and workarounds. Specific Aim 3: To demonstrate utility of low-level information pieces as design bases for cognitive work support, we will test two research interventions: (1) design an information-action interface with information pieces and associated properties, and test situation awareness of providers with the new interface; (2) augment selected existing IT support in the discharge process with new low-level information-based design features from our work to see if workarounds are reduced. With our work, we expect to revolutionize design and analysis of information support for cognitive work in healthcare, the way model-control-view framework of software has revolutionized software engineering.